Mechanisms of Biological Aging of Cochlear Hair Cells

Age-related hearing loss (ARHL), the most prevalent form of hearing loss in humans, is commonly caused by
degenerative changes (or biological aging) and apoptosis of the cochlear inner and outer hair cells (IHCs, OHCs).
Despite the fact that ARHL has been extensively studied using various mouse models, the causes of hair cell
aging and apoptosis are still largely unknown. Our long-term goal is to examine the cellular and molecular
mechanisms of biological aging of IHCs and OHCs. In the first part of the proposal we will attempt to answer
two critical questions of how cochlear hair cells undergo aging, and why hair cell degeneration proceeds from
the basal to the apical turn and from OHCs to IHCs. In the second part, we will focus on the molecular
mechanisms of why OHCs are more susceptible to aging or other insults than IHCs by determining the roles of
Clu, a gene that is differentially expressed in OHCs. A battery of electrophysiological, immunohistochemical,
advanced imaging, and molecular biological techniques will be used to examine cellular changes in ultrastructure
and mechanical and electrophysiological properties of IHCs and OHCs in the base and apex of the cochlea,
respectively, in CBA/J strain mice during aging. Our hair cell-specific RNA-seq experiments using IHCs and
OHCs obtained from younger and aging mice will enable us to reveal molecular mechanisms by identifying genes
underlying age-related changes in IHCs and OHCs. We have three specific aims. Aim 1 is to examine the
changes in mechanotransduction and mechanical and electrophysiological properties of hair cells during aging.
Aim 2 is to examine the changes in gene expression underlying molecular mechanisms of aging of IHCs and
OHCs. Aim 3 is to test the hypothesis that the elevated levels of Clu expression in OHCs relative to IHCs play a
key role in the OHC’s selective susceptibility to aging. Completion of these aims is critical to understand the
intrinsic cellular and molecular mechanisms of hair cell aging. The knowledge gained from this research is also
essential for identifying targets for therapeutic intervention that aims to decelerate ARHL.

Public health relevance
Age-related hearing loss, the most prevalent form of hearing loss in humans, is commonly caused by degenerative changes and apoptosis of the cochlear hair cells. Understanding the intrinsic cellular and molecular mechanisms of hair cell aging is critical for designing strategies for therapeutic intervention that can treat and/or delay age-related hearing loss.